Center for Protein Structure and Function

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. For research into new antiviral medications via consideration of opposing actions of virus-specific and host proteins that function as part of a body's viral defense mechanism.